CE25-026 - Evaluation of the school-based Healthy Relationships Project for primary prevention of child sexual abuse and problematic sexual behaviors among youth in 7th and 8th grades

Project Abstract
Evaluation of the school-based Healthy Relationships Project for primary prevention of child sexual
abuse and problematic sexual behaviors among youth in 7th and 8th grades
Child sexual abuse (CSA) is a major issue worldwide, with rigorous evidence of its magnitude and impacts on
social, emotional and physical health. Problematic sexual behavior (PSB) among youth, or youth-perpetrated
CSA, accounts for more than 70% of CSA experiences (Gewirtz-Meydan A et al. 2019). While interventions for
CSA primary prevention exist, few have been rigorously evaluated and even fewer focus on PSB. A review of
school-based CSA prevention programs (Walsh et al., 2015) found 24 trials elementary and high schools across
7 countries that showed evidence of improvements in protective behaviors and knowledge, but no changes in
CSA incidence/prevalence. The Healthy Relationships Project (HRP) created, modified, and run by Prevent Child
Abuse Vermont, has been delivering CSA primary prevention curricula, with PSB prevention as a major
tenet, since 1990 with implementation across 30 U.S. States, including statewide in Vermont. Substantiated
cases per year in Vermont dropped 61% and importantly for this proposed evaluation, the number of child
perpetrators per year dropped 69%. Utilizing a stepped wedge randomized trial design, we will evaluate the 10-
lesson Sexual Abuse Free Environment for Teens (SAFE-T) curriculum of the HRP, and TECHNICOOL, an
internet safety workshops for caregivers, in 16 schools with 7th and 8th grade students. SAFE-T uses an upstream
universal public health approach for primary prevention of youth problematic sexual behaviors with
developmentally appropriate intervention elements for youth, faculty/staff, and caregivers. Longitudinal data will
be collected on key outcomes, including improvements in protective behaviors, self-efficacy, and knowledge
among students and adults, and CSA-related incident school reports. This program will meet criteria for the 2018
School Safety Omnibus Amendment Act that obligates DC schools to address sexual abuse prevention. Our
implementation partner, MCSR, has outstanding relationships with Washington, DC schools. MCSR has a long
history of implementing evidence-based, gender-based violence prevention programs including the Men of
Strength (MOST) Club and Women Inspiring Strength and Empowerment (WISE) Club in over 120 locations
across 34 states, and Washington, DC. Our evaluation team has demonstrated success in a similar trial of HRP
curricula for pre-K through 5th graders in 12 public/public charter schools in DC, with an additional 4 schools
scheduled. Qualitative research will assess strengths/weaknesses of intervention rollout, fidelity monitoring,
lessons learned, and sustainability. This innovative, novel mixed methods evaluation study will move the science
of CSA/PSB prevention research forward with a community-based participatory research partnership between
prevention research scientists, community-based organizations, and public schools in high need, diverse urban
areas. In summary, a rigorous experimental evaluation will be conducted of an existing universal
primary prevention program for child sexual abuse and problematic sexual behavior among 7th/8th
graders, a program with 30+ years of implementation history in 30 U.S. states and robust pilot data.

Public health relevance
The proposed research has enormous public health implications given the tremendous burden of child sexual abuse and problematic sexual behavior by youth on social, emotional and physical well-being. Evidence-based primary prevention interventions to eliminate child sexual abuse and problematic sexual behavior by youth are needed; this study has the potential to demonstrate the efficacy of the Sexual Abuse Free Environment for Teens (SAFE-T) curriculum for youth, and TECHNICOOL for caregivers, of the Healthy Relationships Project (HRP), a program that has been operating for over 30 years, in 38 U.S. states. This innovative and novel stepped wedge cluster randomized trial of HRP conducted in 16 high need Washington, DC public and public charter schools, carried out by a highly skilled academic/community-based partnership, will have the methodological rigor and community input to make contributions to the field about how to implement and sustain a highly regarded and feasible school-based primary prevention intervention for child sexual abuse and problematic sexual behavior by youth in 7th and 8th grades, possibly elevating it to the echelon of evidence-based programming.